OUTREACH AND EDUCATION TO HEALTH CARE PROVIDERS ON SUBSTANCE USE, CONTRACT TYPE: COST PLUS FIXED FEE (TERM/LEVEL-OF-EFFORT); POP: 3/08/20 - 3/07/21

The objective of this contract is to provide NIDA with continuation of a national outreach and communications program, NIDAMED. The Contractor shall conduct formative research to develop new products/materials and to identify ways to best disseminate products/materials to clinicians. This contract seeks to continue development of existing products and materials and create new products and materials to disseminate to NIDAMED’s clinician and trainee audiences. In addition to marketing and disseminating NIDAMED products/materials, the Contractor shall measure outreach methods and NIDAMED materials/tools usage.